Neuroscience at the Boundaries of Neurology and Psychiatry

[unreadable] DESCRIPTION (provided by applicant): [unreadable] This application responds to RFA #MH-05011, "Course Development in the Neurobiology of Disease," to seek support for the implementation of a course, "Neuroscience at the Boundaries of Psychiatry and Neurology" (NBPN). This course addresses the requirements of this RFA, providing an educational experience for graduate students that "will span a breadth of diseases and disorders affecting the nervous system, emphasizing links and common themes across diseases/disorders, and addressing both pathology of these diseases/disorders and their basic science underpinnings." NBPN is a 2-quarter (22-week) course that will educate future physician-scientists on the clinical and basic neurosciences of 11 brain disorders: Obsessive Compulsive Disorder, Tourette Syndrome, Stroke, Huntington's Disease, Substance Dependence, Autism, Schizophrenia, Seizure Disorders, Parkinson's Disease, Alzheimer's Disease and Neuropsychiatric manifestations of HIV-1/AIDS. Introductory didactic material will include lectures on diagnosis in Psychiatry and Neurology, and "core" topics including neuroanatomy, neurodevelopment, neuroimmunology, neuroimaging, electrophysiology, clinical trial design, drug development, and bioethics. Each disorder is covered in a 3- session unit, with an overview lecture, a patient interview session, and a presentation from an invited expert in a related area of "cutting edge" translational neuroscience research. The curriculum emphasizes phenomenological and mechanistic links and common biological themes across these disorders. The educational value of NBPN will be enhanced by the integration of resources from 6 existing training programs at UCSD (5 existing T32 programs (GM007198, AG000216, DC0041-13, MH020002, MH018399), and a sixth under review (UCSD Neurosciences Graduate Training Program)), a process that will also permit both administrative and fiscal efficiency. The Principal Investigator (PI) and Co-Investigator have assembled a team of world-class clinical and basic neuroscientists and educators, many of whom will also serve as an advisory group that will assist in the development, monitoring and evaluation of this teaching program. The contents of NBPN will be disseminated nationally via internet postings. In total, NBPN will achieve the goal of the NIH "blueprint", to educate young physician-scientists in areas of translational neuroscience research, to accelerate the process of translating basic science discoveries into clinical understanding and interventions. [unreadable] [unreadable]